Vasculata Conference 2023

Summary
The Vasculata Conference is an intensive boot camp that was first held in 2004. Under the
auspices of the North American Vascular Biology Organization (NAVBO), Vasculata has a long-
standing history of being hosted at major academic medical centers with the goal of engaging
the next generation of vascular biology investigators. The NAVBO Educational Committee
unanimously selected Tulane University as the host site for the 2023 conference. Vascualta has
grown as a conference with a total attendance of 60 attendees to over 140 at its peak pre-
pandemic. Last year’s conference at Duke University attracted over 125 attendees. By
introducing students and engaging trainees and early career faculty in heart, lung, and blood
related science (HLBS) fields, this conference hopes to attract the next generation of
independent investigators and physician scientists. Emphasis of the 2023 Vasculata Conference
to be held at Tulane University School of Medicine at the Health Sciences Center campus and
co-hosted by Xavier University of Louisiana is on translational science application of vascular
biology and HLBS fields. Additionally, we recognize that without strong mentorship, the steps to
becoming an independent investigator are even more difficult. To that end, we have made
career development and mentorship a key component of the conference this year as well. The
key goal of this meeting is to train the next generation of physician scientist and investigators,
attract underrepresented minorities including women to HLBS research, and provide career
development and mentoring education to allow growth of these early career researchers. In
order to facilitate this goal, we propose the following objectives:
1. To facilitate exposure of underrepresented minorities and women to HLBS research.
2. To dispense basic and current knowledge in HLBS research.
3. To conduct workshops that introduces current and emerging methods in HLBS
research.
4. To educate trainees regarding professional career paths in HLBS research.
To facilitate these objectives, we request limited funds from NHLBI to offset some of the costs
associated with hosting this conference at Tulane University /Xavier University of Louisiana.
Accomplishing these objectives will increase representation of underrepresented minorities in
HLBS research and will train and prepare next generation to the future of HLBS research.
These goals are directly aligned with the training and research mission component of NHLBI.

Public health relevance
Narrative The primary objective of the Vasculata Conference 2023 being held at the Tulane University School of Medicine, Health Sciences Center Campus and co-hosted by Tulane University and Xavier University School of Medicine is to provide a platform for early career investigators and physician-scientists to allow the dissemination of cutting-edge research to a diverse audience in the field of vascular biology. The intensive bootcamp of Vasculata Conferences is ideal to be held at Tulane given the unique translational research and skilled mentors present at the host intuitions, with an aim to recruit underrepresented groups including women into HLBS research fields. This initiative aligns well with the missions of NHLBI, training the next generation of scientists.